Deprescribing for Older Dialysis Patients

ABSTRACT
This is a Beeson Emerging Leaders in Aging career development award (K76) for Dr. Rasheeda Hall, MD,
MBA, MHS. Dr. Hall is a nephrologist who conducts aging research at Duke University, and her long-term goal
is to become a leader in geriatric nephrology and develop effective interventions targeting geriatric conditions
in older dialysis patients. Compared to older adults without kidney disease, older dialysis patients are more
likely develop severe cognitive impairment, experience more falls, and have more frequent hospitalizations.
These adverse outcomes are also known to be associated with potentially inappropriate medications, and older
dialysis patients are highly susceptible to adverse effects of potentially inappropriate medications because of
altered medication clearance due to absent kidney function and common occurrences of hypotension and mini-
strokes. Given this susceptibility, reduction of potentially inappropriate medications is a logical goal for
improving quality of care for these vulnerable patients. The objective of Dr. Hall’s proposed research is to
develop an evidence-based strategy to reduce inappropriate prescribing in older dialysis patients. The
research aims are to: 1) identify the prevalence of specific potentially inappropriate medications and the extent
to which there is an association with hospitalization risk in prevalent older dialysis patients, 2) identify elements
of a deprescribing intervention that are acceptable to nephrologists, primary care providers, and patients, and
3) determine the feasibility of a deprescribing intervention tailored for older dialysis patients. This work will
provide evidence to support a definitive clinical trial of deprescribing in dialysis units. Effective deprescribing
interventions have the potential to reduce hospitalizations and ameliorate geriatric syndromes in dialysis
patients which is consistent with NIA’s mission. Complementary to this research, this career development
award will solidify Dr. Hall’s transition to research independence through coursework and mentoring to: a) fill
knowledge gaps in directing a team of statisticians, interpretation of pharmacoepidemiologic data, advanced
methods in handling bias in observational data, timely qualitative analyses, execution of a pilot study, and
clinical trial design; b) enhance her leadership skills; and c) successfully compete for a R01. Duke University is
the ideal environment for Dr. Hall to pursue this research career development because of the strong aging
research expertise housed in its Center for Aging and affiliated Pepper Center, as well as, rich resources
available through Duke’s Clinical and Translational Institute.

Public health relevance
PROJECT NARRATIVE Older adults receiving dialysis treatments are at risk of using potentially inappropriate medications and experiencing adverse events associated with those medications. This study will examine outcomes associated with select potentially inappropriate medications and pilot test an intervention tailored to reducing use of these medications. For older adults receiving dialysis, this research will have a positive impact on health outcomes and quality of life.